POSSIBLE REVERSAL OF COGNITIVE DEFICITS IN A PATIENT WITH ALZHEIMER'S DISEASE

It is the purpose of this study to determine if the use of estrogen will improve cognition in patients with Alzheimer's Disease.